Data and Resource Coordination Center for Cancer Prevention-Interception Targeted Agent Discovery Program

Project Summary/Abstract: This application is being submitted in response to the Notice of Special
Interest (NOSI) identified as NOT-CA-23-012. The goal of our proposed Data and Resource Coordinating Center
(DRCC) application is to coordinate the activities across the Cancer Prevention-Interception Targeted Agent
Discovery Program (CAP-IT), and to manage, integrate and disseminate the data and resources generated
through the network. Leveraging cutting-edge multi-disciplinary team approaches, we will support the CAP-IT to
discover molecularly or immunologically targeted agents designed to prevent or intercept the oncogenic process
for precision cancer prevention and interception. Our strategy is to enhance the productivity of CAP-IT
investigators by fostering a collaborative and synergistic research community, accelerate the progress of CAP-
IT research by reducing barriers to accessing analytics expertise, ensure the reproducibility of CAP-IT data by
deploying best practices for data acquisition and harmonization, and unleash the full potential of CAP-IT activities
by developing enhanced tools to enable resource sharing to the broader scientific community.
First, we will provide a centralized administrative infrastructure to coordinate CAP-IT activities, building
upon our well-functioning infrastructure that currently coordinates network studies under the umbrella of the NCI
Cancer Moonshot initiatives. Second, we will actively promote the CAP-IT and engage in trans-consortium
interactions, where we will leverage our demonstrable experience in Cross-Moonshot outreach and
Bioconductor’s decades-long record in community engagement. Third, we will, in coordination with each CAP-
IT center’s informatics group, provide multidisciplinary analytics expertise to support CAP-IT’s collaborative
research, leveraging three of Roswell Park CCSG’s shared resources: Biostatistics, Bioinformatics, Biomedical
Informatics. Fourth, we will develop improved data integration and analysis software, database and workflows to
enhance CAP-IT’s research capacity, capitalizing on our extensive track-record in developing NIH-supported
Cancer Moonshot, Bioconductor and AnVIL ecosystems. Taken together, we envision that our DRCC, in close
collaboration with the CAP-IT U54 Centers and NCI staffs, will allow us to support highly effective and innovative
translational studies to address the significantly unmet needs related to precision cancer prevention-interception.
The main deliverables from the proposed aims will be administrative and outreach support to coordinate
network activities, facilitate network collaboration, and engage in interaction with the broader community (Aim
1); workflows to ensure that all data generated by the CAP-IT will be harmonized using standards interoperable
with the broader cancer data ecosystem, analysis tools and database to integrate CAP-IT data and facilitate
cross-study analysis, and multidisciplinary analytics supports to accelerate CAP-IT research progress (Aim 2);
polices and infrastructures to ensure that all resources generated by the CAP-IT will be findable in a centralized
virtual information hub, and that all resources will be shared with the broader scientific community (Aim 3).

Public health relevance
Project Narrative To close the gap in discovering and bringing risk-tailored targeted agents to the higher-risk populations for cancer prevention and interception will require collaborative efforts to identify potentially exploitable oncotargets, validate their oncogenic characteristics, discover innovative targeted agents, and advance promising efficacious agents for further development. The goal of our proposed Data and Resource Coordinating Center (DRCC) application is to coordinate the activities across the Cancer Prevention-Interception Targeted Agent Discovery Program (CAP-IT), and to manage, integrate and disseminate the data and resources generated through the network. Leveraging cutting-edge multi-disciplinary team approaches, we will support the CAP-IT to discover molecularly or immunologically targeted agents designed to prevent or intercept the oncogenic process for precision cancer prevention and interception.